Targeting age-associated decline in brain function with the extracellular vesicle

ABSTRACT
The naked mole rat (NMR) is a mouse-sized rodent that lives over 30 years. Considering that large mammals
live longer than small mammals, the NMR has emerged as a novel animal model for aging studies. Its
exceptional longevity is associated with other phenotypes, such as unusual thermogenesis, extremely low
cancer incidence, resistance to hypoxia, and
protected from Alzheimer’s disease. We developed and
characterized NMR induced pluripotent stem cells (iPSCs). The NMR iPSCs displayed a characteristic
morphology, expressed pluripotent markers, formed embryoid bodies, showed typical differentiation patterns,
and differentiated into all three germ layers, but failed to form teratomas.
We are particularly interested in exosomes isolated from NMR fibroblasts as they may hold the characteristics
of NMR longevity and anti-AD/ADRD. Exosomes are fingerprints of originating cells and feasible to transfer the
genetic materials to the other organisms. In addition to the genetic materials encapsulated in exosome,
exosome also carry small molecules.
We aim to isolate exosomes from NMR fibroblasts of long-living rodent, naked mole rat that carry pro-longevity
materials transfer to mouse to modify the aging-associated pathology such as AD/ADRD, and lifespan of the
recipient mouse.

Public health relevance
NARRATIVE Among healthy older adults, brain aging process is typical and resulted in neurocognitive changes and Alzheimer's disease (AD/ADRD). Although some treatments for its symptoms are available, many functional declines of brain have no known cure. We aim to restore health to brain by extracellular vesicles isolated from naked mole rat fibroblasts.